Centrosome regulation of trafficking, ciliogenesis and cilia-dependent signaling

PROJECT SUMMARY / ABSTRACT Centrosomes are the central organizing centers of cells, performing essential functions for mitotic spindles and cilia. Diverse human diseases arise from defects to centrosomes because they impact both mitotic and ciliary functions. We discovered that cells from individuals with Down syndrome have both defective centrosomes and cilia. This opens an important new avenue for understanding the cell biological basis of Down syndrome. Because primary cilia loss is developmentally lethal, our studies will explore the role that subtle changes to centrosomes have in controlling cilia formation and function. Central to the reduced cilia function in Trisomy 21 cells, we discovered that elevated expression of the Pericentrin gene, encoded on chromosome 21, is necessary and sufficient to repress the movement of components required for both cilia formation and function from the cytoplasm to the centrosome and cilium. Pericentrin is a centrosome and intracellular trafficking scaffold protein that dramatically increases and decreases during the cell cycle, with levels lowest when cilia formation occurs and highest during mitosis. We propose that exquisite control of Pericentrin ensures cilia formation and function. However, we do not understand why the modest 1.5-fold increase in Pericentrin protein found in Down syndrome has such a profound impact on cilia. We will test how decreased and increased Pericentrin levels impact centrosomes, the interphase microtubule landscape, and satellite and vesicular trafficking, and what the consequent outcomes for cilia formation and signaling are. Excellent training opportunities exist for undergraduate and graduate students and postdoctoral researchers in the Pearson lab. We will continue to use and develop our rigorous training and experimental routines in alignment with the NIH guidelines for increasing rigor and reproducibility. Collaborations with other labs that specialize in electron microscopy and machine learning quantitative analyses will expand the innovation and impact of our studies of intracellular trafficking. In summary, this proposal will illuminate how the precise control of the human disease protein, Pericentrin, is coordinated with the cell cycle to ensure proper primary cilia formation and signaling required for normal development. This application aims to elucidate fundamental cell biological events in intracellular trafficking, cilia formation and cilia-dependent signaling that are commonly defective in human disease.

Public health relevance
PROJECT NARRATIVE Down syndrome is caused by an extra copy of chromosome 21 and, like ciliopathy patients, individuals with Down syndrome display variably penetrant pathologies including cardiac septal defects, craniofacial dysmorphology and cognitive abnormalities. We discovered that Trisomy 21 and elevated gene dosage of the Pericentrin gene present on chromosome 21 inhibits cilia formation and signaling. Our research aims to determine the fundamental cellular basis for cilia defects in Down syndrome and how changes to Pericentrin levels tune centrosome structure, intracellular trafficking, ciliogenesis and cilia-dependent signaling during the cell cycle.